Project 3:Isolation Chemistry of Filamentous Fungi and Biological Evaluation

PROJECT SUMMARY – PROJECT 3
There is a need for new anticancer drug leads, particularly for treating drug- resistant cancers. Fungi have been
the source of many drug leads, with penicillin and the statins as two of the most prominent examples. It is
hypothesized by Project 3 that fungi harbor anticancer drug leads, and we are addressing this via a team with
expertise in mycology (Mycosynthetix, Inc./Pearce), natural products chemistry (UNCG/Oberlies), and chemical
biology (Columbia/Stockwell).
In the examination of thousands of fungal cultures from the Mycosythetix Inc.library, Project 3 has implemented
biological and chemical protocols to prioritize our efforts. In doing so, we have identified hundreds of fungal
metabolites with anticancer activity, approximately a third of which are new to the literature. Currently, we have
prioritized three of these leads for further preclinical development, and our team is optimizing the biosynthesis
of materials (targeting gram scale production) for pharmacology studies, PK/metabolism, and semi-synthetic
optimization. One of these leads (verticillins) has shown a statistically significant response in an in vivo model of
ovarian cancer. Another lead, eupenifeldin, showed a statistically significant response in an in vivo model of
tumor resection in lung cancer. Both of these are undergoing further development, particularly lead optimization
via semi-synthesis. A third lead is derived from fungal-fungal co-culture studies, which was an area of emphasis
in the previous submission.
An additional goal for generating new chemical diversity is the biosynthesis and/or semi-synthesis of non-natural
natural products, via the incorporation of fluorine atoms into the privileged fungal-derived scaffolds. There are
several areas documented in the proposal that demonstrate our team’s ability to leverage ideas and
collaborations to further advance promising fungal metabolites.

Public health relevance
PROJECT NARRATIVE – PROJECT 3 Our team will study fungal cultures as a source of new anticancer drug leads. We have a strong track record of success, having identified and studied hundreds of fungal metabolites with anticancer activities. This proposal builds upon past success by adding a new target, drug-tolerant persister cells, via our collaboration with Columbia University. It also documents the many ways that we leverage research relationships and innovative ideas to push our best leads into further development.